Improving Clinical Trial Recruitment and Outcome Measures in Bullous Pemphigoid

Project Summary/Abstract
This proposal fits the mission of the NIAMS Clinical Observational Studies R01 FOA to enhance
the quality of clinical trials for patients with bullous pemphigoid (BP). The overall objective of this
proposal is to better characterize changes in disease activity, pruritus in a prospective manner
and capture patient reported outcomes that could be utilized to design better therapeutic trials.
Dr. Feldman at Emory University has accumulated years of experience in treating and measuring
disease activity from a large group of BP patients referred from all over the Southeastern US.
Many of the clinical measurement tools in BP have only recently been validated and have not
been rigorously applied in a prospective fashion, in the absence of which, designing a future trial
is quite impractical. The research strategy is to follow patients over a 4 month period with monthly
visits in which both objective and subjective measurements will be assessed. Since BP is a rare
disease, more effective recruitment and retention strategies are necessary to improve enrollment.
Aim 1 will prospectively monitor changes in the Bullous Pemphigoid Disease Area Index (BPDAI)
over a defined time of 4 months, and we propose to quantify the change in BPDAI total activity of
≥50% as a benchmark clinical endpoint for treatment efficacy. In addition, specific changes in
patient reported outcomes over the 4 month period will be assessed with emphasis on change in
pruritus as measured by the Itching Quality of Life measurement, ItchyQoL. The primary outcome
will be improvement in the ItchyQoL and this changing frequency will be compared to BPDAI
activity and pruritus scores. The recently validated autoimmune blistering disease specific quality
of life measurements will also be utilized as secondary outcomes. Aim 2 will explore innovative
methods to improve patient recruitment/retention for future trials in which we plan to leverage the
existing teledermatology network across the State of Georgia to allow patients to be followed
remotely between clinic visits. The primary goal is to assess patient satisfaction with
teledermatology visits, thus improving compliance by not having to travel long distances for on-
site visits. Secondary goals include assessing the feasibility of BPDAI scoring based on photo
images compared to face-to-face. Importantly, development of this teledermatology infrastructure
will facilitate future clinical trials moving forward. Data from this proposal will be essential for
designing future clinical trials in BP with appropriate repeated measurements, benchmark
outcomes for both objective and subjective qualities with improved patient engagement.

Public health relevance
Project Narrative This prospective observational trial will provide data to help design and implement future clinical trials in bullous pemphigoid. The goals are to develop improved recruitment and retention strategies utilizing a hybrid trial approach in which Teledermatology visits alternate with traditional on-site visits. In addition characterization of the natural disease activity over specific time periods with appropriate changes in objective measurements will inform appropriate trial endpoints. Finally improved understanding of the quality of life impact, particularly related to pruritus will be essential for optimal therapeutic trials.